Symposium on AI in VeterinarY Medicine (SAVY): Intersectionality of artificial intelligence with companion animal health, livestock health, and population medicine

Project Summary/Abstract
There is tremendous growth and potential in the development, application, and clinical use of artificial
intelligence (AI) in healthcare, and the emergence of AI in veterinary medicine poses exciting and new
opportunities to improve the quality of life of animals with direct and indirect benefits to human health at the
individual and population levels. This proposal requests partial support for a Symposium on Artificial
Intelligence and VeterinarY Medicine (SAVY) to be held at the Cornell College of Veterinary Medicine, October
4-6, 2023, immediately before one of the largest veterinary conferences in the USA (NY State Veterinary
Conference), also held on Cornell’s campus. The purpose of this symposium is to provide, for the first time,
an opportunity for discussion and collaboration amongst researchers who focus exclusively on the
intersectionality of veterinary medicine and artificial intelligence, foster cross-disciplinary discussions and
collaborations, and provide an opportunity for students, faculty, and the private sector to learn from each other
in this rapidly developing field. The significance of this symposium is that it provides a platform to discuss
these innovations, how they might affect clinical practice of veterinarians, the quality of life of animals, and
socio-economic and environmental factors. The objective of this symposium is to provide an open and
welcoming place for learners, researchers, clinicians, and industry leaders to discuss the future of AI in
veterinary medicine. Our specific aims will be to i) host a 2.5 day symposium on veterinary medicine and AI
within four focus areas: population medicine, companion animal medicine, livestock health, and human
medicine; ii) provide modest to free registration fees for attendees to reduce barriers to this content; iii)
organize and summarize a 0.5 day workshop for attendees to identify and address areas of research; and iv)
publish and digitally archive presentations. Four world-leading AI researchers who focus on (i) human
medicine, (ii) companion animal health, (iii) population medicine, and (iv) livestock health will be invited for
keynote presentations, examining different AI approaches, such as computer vision, natural language
processing, and speech recognition. Invited speakers and presenters will be carefully considered to ensure
diversity in attendees, expertise, perspectives, and practices. This program will be offered immediately before
one of the largest veterinary conferences in the USA (NY State Veterinary Conference), permitting the
opportunity for attendees to enhance their learning experience while in Ithaca NY. The conference will be in-
person and university resources will be leveraged to publish and archive presentations. Continuing education
credits for professionals who would require it for their certification(s) will be obtained.

Public health relevance
Narrative Artificial intelligence is a broad and growing discipline that touches many facets of everyday life for humans and is more recently emerging in veterinary medicine through topics like companion animal health, population medicine and zoonotic diseases, and digital agriculture and food sustainability. While there has been considerable growth in the use of AI in human medicine, to date, there has been no concerted effort to bring veterinarians practitioners and AI researchers together and share knowledge. This symposium, the first of its kind, will provide a forum for veterinarians, computer scientists, medical professionals, and other disciplines to share expertise and knowledge, identify research focus areas and priorities, within an open, diverse, and inclusive environment.